RACIAL DIFFERENCES BETWEEN INSULIN RESISTANCE AND BLOOD PRESSURE

The purpose of this study is to compare the effects of insulin on sympathetic nervous system activity, renal hemodynamics and renal tubular function in normo-tensive and hypertensive subjects of three different racial groups--white, black and Mexican-Americans.